Advanced development of a viral entry inhibitor as a therapeutic for arenavirus hemorrhagic fever

PROJECT SUMMARY
This project is focused on developing a broad-spectrum antiviral drug for treating viral hemorrhagic fever
diseases caused by Old World and New World arenaviruses. There are no FDA-approved therapeutics for
treating infections caused by these viruses, and hemorrhagic fever arenaviruses are listed as NIAID
Category A priority pathogens. Our small-molecule drug, LHF-535, is an investigational new drug (IND)-ready
oral antiviral therapeutic against Lassa virus, an Old World arenavirus that causes Lassa fever. The drug
targets the Lassa virus envelope glycoprotein and functions as a viral entry inhibitor. In this project, our goals
are to assemble a data package to expand the labeled indication for LHF-535 to include infection with the New
World hemorrhagic fever arenaviruses Junín virus and Machupo virus, address pre-IND recommendations by
the FDA to more fully characterize the genotypic and phenotypic characteristics of arenaviruses that develop
resistance to LHF-535, and formulate LHF-535 for intravenous (i.v.) administration. To achieve these goals, the
following Specific Aims are proposed: 1) Define the antiviral activity of LHF-535 against New World
hemorrhagic fever arenaviruses. Junín virus and Machupo virus are endemic in distinct regions of South
America, where they cause sporadic outbreaks of severe disease with high morbidity and mortality. We will use
well-established guinea pig infection models to define antiviral efficacy and to determine pharmacokinetic-
pharmacodynamic relationships. 2) Determine the nature, emergence, and virulence of LHF-535-resistant
viruses. We will evaluate the ability of LHF-535 to inhibit the infectivity of lentiviral pseudotypes expressing
envelope glycoproteins of Junín virus that contain specifically engineered amino acid substitutions. Junín virus
variants that are resistant to LHF-535 will also be identified by serial passage in LHF-535-treated cells and by
isolating viruses from animals that fail LHF-535 treatment. To assist in monitoring the development of antiviral
resistance during initial clinical efficacy studies, we will also generate and test an expanded library of genetic
variants within the Lassa virus envelope glycoprotein. 3) Develop an i.v. formulation for LHF-535. Intravenous
administration provides an option for drug delivery in situations where oral administration is not feasible. We
will also explore the possibility that the rapid drug exposure provided by i.v. administration might enhance
therapeutic efficacy, particularly in late stages of disease. Formulation development will include evaluation of
antiviral efficacy (including fixed-dose and loading-dose strategies), toxicology, and safety pharmacology.
Together, our studies will enhance the clinical value and efficacy of LHF-535 across multiple indications and
support and inform Phase II clinical trials. LHF-535 is intended to both improve global health and serve as a
medical countermeasure to the bioterrorism threat posed by hemorrhagic fever arenaviruses.

Public health relevance
PROJECT NARRATIVE This project is focused on advanced-stage development of LHF-535, an oral antiviral drug for treating Lassa fever, an arenavirus-caused hemorrhagic fever disease that is prominent in West Africa. Our goals are to establish whether LHF-535 can also be used to treat Argentine hemorrhagic fever and Bolivian hemorrhagic fever, to determine how arenaviruses may develop resistance to the drug, and to formulate the drug so that it may also be given intravenously. Because no drugs are approved for treating these diseases, LHF-535 is intended to improve global health and serve as a biodefense medical countermeasure.